Advanced Technology to Study Visual Function on a Cellular Scale

Project Summary
We are asking for support to continue to develop and enhance three state-of-the-art optical instruments that
will be used to answer questions about the most important and the most challenging region in the retina to
study, the fovea. The instruments are built upon two key technical strengths - adaptive optics scanning laser
ophthalmoscope (AOSLO) systems and accurate, high-speed eye-motion tracking. Adaptive optics technology
corrects the imperfections in the eye and can be used to generate microscopic views of the living retina and
deliver ultra-sharp images to the retina. Eye tracking is used to measure and compensate for ever-present eye
motion. Together, these allow for visualization, tracking and delivery of light to retinal features as small as
single cone photoreceptors, enabling measurements of properties of spatial and color vision on an
unprecedented scale. Although the three systems will be identical, the scope of study for each system will be
very different. The AOSLO at in Alabama will be used to test vision in non-human primates, the AOSLO in
Berkeley will be used to perform advanced vision testing on healthy human eyes, and the AOSLO in San
Francisco will be used to study patients with eye disease. The key advantage of having the BRP manage three
identical systems is that it will facilitate hardware innovations plus rapid translation of knowledge and
innovative testing from animal models to the clinic. Briefly, the specific aims are:
Aim 1: Advanced AOSLO display capabilities for color vision: We propose a series of technical
developments will expand the scope of AOSLO experiments, not just for color vision, but also spatial vision
and clinical applications. Specifically, we will (i) add 2-photon stimulation (ii) develop new methods to display
large stimuli that are fixed in world-coordinates (iii) integrate dichoptic displays to enable experiments that
distinguish retinal from cortical visual processing (iv) develop I-TRACK (improved software tools for retina-
contingent vision testing) and (v) invisible imaging and tracking. These tools will enable a series of experiments
to learn how the visual system extracts color and spatial information from its sensory inputs.
Aim 2: Enhanced AOSLO systems and modeling for spatial vision: In this aim we will (i) develop
advanced wavefront propagation tools to model light-cone interactions (ii) integrate AOSLO microstimulation
with a system for 2-photon functional brain imaging in non-human primates. We aim to use these tools to
greatly enhance our understanding of receptive fields at and near the fovea.
Aim 3: Clinical translation: We will integrate the new technology into the system at UCSF to (i) study rod
vision in patients with rod-cone degenerations (ii) measure the time course, structure and function of
dysflective cones (iii) investigate the structure and function of the preferred retinal locus in diseases that affect
the fovea and (iv) assess inner retinal function in eye disease.

Public health relevance
Project Narrative The Bioengineering Research Partnership proposes to develop and enhance capabilities of three state-of-the- art systems that enable the study of vision in living eyes on a cellular level. By deploying and using these systems in three environments – vision testing in animal models, vision testing in healthy normal eyes and vision testing in patients – we outline an effective strategy for answering long-standing questions about foveal vision, and also provide a means for efficient translation of technology into clinical applicability.